Psychosocial and cultural determinants of cardiometabolic health among older Chinese Americans

Project Summary
Cardiometabolic diseases contribute to more than 1 in 4 deaths in U.S. adults, including Asian Americans.
Psychosocial stress is believed to be a key risk factor leading to elevated risks of cardiometabolic diseases,
beyond traditional factors such as poor diet and physical inactivity. However, there is limited knowledge of how
psychosocial stress affects cardiometabolic health among Asian Americans, especially older foreign-born
Asian American who disproportionately encounter psychosocial stress due to racism, language barriers, and
low socioeconomic status. Notably, a lack of knowledge of key biopsychological mechanisms through which
psychosocial stress affects cardiometabolic health hampers public health efforts to develop effective
interventions to promote cardiometabolic health in the understudied Asian American population, which is
projected to reach 46 million by 2060. To address these important scientific gaps, the proposed study is to
investigate key biopsychological processes through which daily psychosocial stress affects cardiometabolic
health among 300 older foreign-born Chinese Americans. We will use a prospective design and harness the
power of ecological momentary assessment and biospecimen sampling to achieve three specific aims. We
propose to: (Aim 1) determine the mediation effects of biopsychological processes (daily negative emotion,
saliva cortisol secretion, daily sleep quality) on the associations between psychosocial stressors (e.g., social
isolation) and cardiometabolic health (e.g., blood pressure, Hemoglobin A1C); (Aim 2) investigate micro-level
day-to-day associations among psychosocial stressors, biopsychological processes, and blood pressure; and
(Aim 3) examine the moderation roles of sociocultural factors (e.g., acculturation, social cohesion) on the
longer-term effects of psychosocial stressors on cardiometabolic health. Completion of the proposed study will
provide new knowledge to facilitate the understanding of key psychosocial stressors and related
biopsychological processes contributing to poor cardiometabolic health in older Chinese Americans. As a
result, this project will guide the design of future culturally-tailored, time-sensitive, personalized psychosocial
interventions that aim to promote cardiometabolic health in this population.

Public health relevance
Projective Narrative Examining biopsychological mechanisms through which psychosocial stress contributes to poor cardiometabolic health in older Asian American immigrants is a critical area for public health, as cardiometabolic diseases are leading causes of death among Asian American immigrants. This study aims to investigate the psychosocial and cultural determinants of cardiometabolic health and key biopsychological processes underlying these relationships using a prospective design. Study results will inform future culturally- tailored public health interventions to promote cardiometabolic health for older Asian American immigrants.